TRD3: Intelligent Physics-Driven Technologies for Inverse Problems in UHF Applications

Project Summary/Abstract
Image reconstruction has been an integral part of MRI technology development over the past decades,
spanning techniques such as parallel imaging, compressed sensing, low-rank matrix models, methods for
novel encoding strategies/k-space trajectories, and more recently deep learning (DL) approaches. Our TRD in
the first phase has been at the forefront of these developments, introducing multiple new technologies for
improved DL reconstruction and training, interpretable image denoising, and fast iterative algorithms, which
were applied to Cartesian, non-Cartesian and novel encoding strategies beyond Fourier encoding. These new
MRI reconstruction methods have also pushed the imaging technologies in other TRDs, CPs and SPs forward
to target higher resolutions and acceleration rates at lower signal-to-noise ratios (SNR), as well as to combine
information across multiple nuclei or even modalities. Consequently, these targets necessitate newer
technologies for image reconstruction and denoising, an interplay with image acquisition, and new approaches
for multi-nuclei and multi-modal computational imaging. Each of these directions correspond to a specific
inverse problem with its own distinct forward operator dictated by the underlying imaging physics.
Our goal in this TRD is to link these inverse problems through the lens of intelligent physics-driven
technologies that synergistically utilize imaging physics and advances in DL methods. For accelerated high-
resolution imaging, which remains a focal point for our TRD, we will develop a new computational imaging
pipeline that explicitly combines interpretable denoising methods and physics-driven DL reconstruction. These
will be complemented by new technologies for improved denoising of MR image series, and for self-supervised
training of physics-driven DL reconstruction from few examples without ground-truth data. On the acquisition
side, we will concentrate on parallel transmit technology for UHF imaging. We will tackle issues related to the
high computational complexity and sub-optimality of existing methods by proposing an unsupervised DL
approach. We will then augment this strategy by incorporating hard constraints on maximum voltage, power
and specific-absorption-rate into DL optimization. We will further investigate new classification-type strategies
for pulse selection towards calibration-free parallel transmit. Finally, we will also pursue developments for
multi-nuclei MRI and multi-modal neuroimaging. For the former, we will develop a physics-driven DL framework
for joint reconstruction of simultaneous/interleaved multi-nuclei acquisitions, using signal intensity informed
multi-coil encoding operators and an additional cyclic loss term to ensure consistency across the different
proton and x-nuclei resolutions. For the latter, we will adapt our interpretable motion-insensitive denoising
strategies to optical imaging, incorporating new forward operators and noise models, while decoupling motion
correction from denoising.